Novel AI-driven music-based intervention to reduce behavioral and psychological symptoms for people living with dementia

PROJECT SUMMARY/ABSTRACT
Alzheimer’s disease and related dementias are often characterized by behavioral and psychological symptoms
of dementia (BPSD) such as agitation, anxiety, and depression. Pharmacological treatments are costly and can
have serious side effects. Music-based interventions (MBIs) may be effective non-pharmacological
interventions, but are not feasible because they present several practical limitations to personalize the
intervention or time its delivery. Limitations include the need for trained staff and asking people living with
dementia for their explicit feedback (e.g., to verbally convey their music preferences).Thus, there is an unmet
need for easy-to-use, practical and effective MBIs to treat BPSD.
Pilot studies with healthy adults and people living with dementia show that the Rubato MBI addresses this
unmet need by using artificial intelligence to automatically create biometrically personalized music playlists
targeted at reducing BPSD. The Rubato MBI personalizes the music intervention automatically without a
trained professional, relying only on physiological cues of stress and not requiring individuals living with
dementia to communicate verbally.
This Phase I study conducted with people living with dementia residing in nursing homes will develop and
validate a protocolized, biometrically-tailored Rubato MBI that is safe, feasible, and acceptable; and
demonstrate the reliable collection of outcomes that may be affected by the Rubato MBI.
The study’s specific aims are:
Aim 1 – Enhance the Rubato MBI with real-time alerts when residents of the nursing home reach a certain
stress level, giving staff the options to do nothing, go to the resident and start the Rubato MBI, or remotely
start/stop the Rubato MBI; and
Aim 2 – Assess how feasible, acceptable and satisfactory the Rubato MBI may be for reducing BPSD
among people living with dementia residing in nursing homes.

Public health relevance
PROJECT NARRATIVE Pharmacological treatments of the behavioral and psychological symptoms of dementia (BPSD) that often characterize Alzheimer’s disease and related dementias – such as agitation, anxiety, and depression – can be very costly and present serious side effects. Music-based interventions (MBIs) may be effective alternative treatments, but are not feasible because they present several practical limitations. This Phase I study assesses the feasibility and acceptability of an enhanced version of the Rubato MBI to treat BPSD in people living with dementia residing in nursing homes after several pilot studies showed that its AI-based music-personalization method addresses the limitations of other MBI approaches.